Structural and dynamic basis for PRKACA-dependent signalopathies

The PRKACA gene encodes for the catalytic subunit of protein kinase A (PKA-C). Recent ge-
nomic efforts have identified several single-site mutations, insertions, and aberrant fusions directly
linked to endocrine diseases. Specifically, a few somatic or germline mutations/insertions have
been linked to adenoma-associated Cushing’s syndrome and its associated cardiac myxomas.
Additionally, two chimeras are drivers for fibrolamellar hepatocellular carcinoma (FLHCC) and
intraductal oncocytic papillary neoplasms (IOPNs) of the pancreas and bile ducts. Recent litera-
ture and our preliminary studies suggest dysfunctional spatiotemporal regulation and loss in
substrate specificity of PKA-C may represent common traits for the progression of these dis-
eases. However, there are no conclusive molecular mechanisms underlying the progression of
these diseases. We hypothesize that these PKA-C variants disrupt the allosteric cooperativity that
drives the assembly/disassembly of the regulatory complexes, unleashing active PKA-C. We pro-
pose to use state-of-the-art liquid-state NMR techniques coupled with biophysical and biochemi-
cal approaches to characterize the interactions between PKA-C and its regulatory subunits and
the endogenous regulator PKI. We will assess how mutations, insertions, and fusion chimeras of
PKA-C disrupt intra- and inter-molecular allostery, leading to aberrant regulation and disease.
Understanding the regulatory mechanism of PKA help determine the molecular etiology of these
diseases and aid in the future design of strategies to precisely control the aberrant activity of
kinases.

Public health relevance
The PRKACA gene encodes for the catalytic subunit of protein kinase A. Genetic sequencing identified mutations in the catalytic subunit of kinase A linked to adenoma-associated Cushing’s syndrome, cardiac myxomas, fibrolamellar hepatocellular carcinomas, and intraductal oncocytic papillary neoplasms of the pancreas and bile ducts. We will identify the molecular mechanisms underlying these dysfunctional kinases, paving the way for alternative and innovative therapies.